Understanding the role of the frontal cortex during cognitive flexibility in Fmr1 knock outs

PROJECT SUMMARY
Autism spectrum disorder (ASD) is a neurodevelopmental disorder where individuals exhibit deficits in
cognitive flexibility. Purpose: This proposal will record from the frontal cortex of Fmr1 KOs (model of Fragile X
syndrome) during cognitive flexibility tasks and assess how neural hyperexcitability within the KOs impacts
reversal learning and shifts of attention. Methods: Fmr1 KOs and wildtype rats will be trained on categorical
perception tasks with touchscreens in operant chambers. Single-unit neurophysiology and local field potentials
will be collected from the frontal cortex (including the anterior cingulate) during the tasks. It is important to
understand how altered neural function within the KOs impacts cognitive function and learning. This project will
compare neural activity from putative pyramidal and interneurons to examine differential functions during
cognition. Examining these differences in neural function between KOs and WT will enhance our
understanding of how cortical excitability impacts cognition. The local field potentials can provide templates of
neural signatures that in future studies can be compared to electroencephalography data from humans with
ASD or Fragile X.

Public health relevance
Project Narrative This project examines the role of the frontal cortex in Fmr1 Knock outs (model of Fragile X) during cognitive flexibility. It is important to understand how altered neural function and hyperexcitability impact cognition. By recording neural activity at the cellular level and with local field potentials, it allows for translational comparisons to human neural data.